PHENYLHYDRAZONES WITH ANTIESTROGEN ACTIVITIES

Substituted benzophenone phenylhdrazones have been synthesized and have demonstrated good anti-estrogen activities with low to absent intrinsic estrogenicity (immature rat uteri assay). 4,4'-Dihydroxybenzophenone-2,4- dinitrophenylhydrazone (A-007) has demonstrated a 38% CR with an overall 25-50% reduction in tumor volume of DMBA induced rat breast tumors. This is in contrast to a 125% increase in tumor volume produced by tamoxifen and an 850% increase seen in the control animals. Studies using the colony forming assay (DFA) documented A-007's ability to inhibit the colonization of human breast and ovarian cancers and normal human endometrial cells. The specific objectives of this Phase I study will be to initiate A-007's rat and mouse acute/chronic toxicity studies and document bone marrow toxicity of A-007 using the granulocyte-macrophage colony forming cell assay (GM-CFC). DEKK-TEC will continue to synthesize and screen substituted hydrazones for antiestrogen and anticancer properties in immature rats and in ZR-75-1 human breast cancer cell in the CFA.